Leveraging biomarkers for personalized treatment of alcohol use disorder comorbid with PTSD

Summary
The Administrative Core for the NYU Langone Center for the Study of Alcohol Use Disorder and Traumatic
Stress will oversee the planning, development, coordination, evaluation, and overall administration of all
research activities across the three Projects and two Resource Cores. Dr. Charles Marmar, MD will be the
Director of the Admininstrative Core. Drs. Arieh Shalev, MD and John Rotrosen, MD will serve as Deputy
Directors. A Program Advisory Board, comprising five leading researchers whose collective expertise aligns
closely with all aspects of the Center’s objectives, will provide extramural evaluation of progress and guidance
to optimize productivity. The specific aims of this Core are to: 1) provide oversight for operational integration of
the three Projects and two Resource Cores; 2) facilitate meaningful interactions and communication among the
Center personnel and the Program Advisory Board; 3) centralize services that ensure compliance with NIH
policy requirements for management of fiscal, personnel, and regulatory functions of the Center; and 4) foster
translational, interdisciplinary research on the comorbidity of alcohol use disorder and post-traumatic stress
disorder at the NYU School of Medicine. The leaders of each project and core will meet with their staff every
week. Dr. Marmar will chair monthly meetings of the entire Center research team and quarterly meettings of
the Steering Committee. The Program Advisory Board will meet with Center Directors and Project and Core
Leads every 6 months to evaluate the progress of each project and adherence to milestones and timelines,
and provide updates. This will ensure that all Center activities remain both on schedule and on budget. An
Enrichment Program will invite visiting scholars to present seminars and to interact with members of the
Center. Hence, the Adminstrative Core will establish and maintain policies for prudent financial management,
ensure regulatory compliance, maximize efficient use and sharing of resources provided by the Cores, and
promote synergistic integration across the Projects.